Novel Adipose Targeted Gene Therapy for Lipodystrophy

PROJECT SUMMARY
Lipodystrophy includes a heterogeneous group of disorders that are characterized by abnormal or
degenerative conditions of the adipose tissue. This rare and often underdiagnosed condition can be
partial/localized or generalized and is typically associated with metabolic disorders such as insulin resistance,
diabetes, hyperglycemia, hyperlipidemia, and other severe conditions. Lipodystrophy can be congenital or
acquired and can often lead to deadly consequences due to liver, kidney, and cardiac complications. All forms
of lipodystrophy have severe insulin resistance and very low leptin levels. Currently, leptin replacement using
Metreleptin is the only approved and recommended treatment of lipodystrophy. However, metreleptin therapy
poses several challenges including poor efficacy, adverse side effects, discomfort of use (1-2 injections per
day), poor compliance and high costs exceeding $1.3 million per patient/year. Zvelt Therapeutics is
developing a safe, efficient, and cost-effective therapy for the treatment of lipodystrophy with long-lasting
effectiveness of at least 5 years. The therapeutic injection, priced at approximately $2M will significantly
reduce the lipodystrophy treatment cost per patient/year by at least 70%. The therapy is mediated by
recombinant adeno-associated virus (rAAV) vectors that offer long-lasting transgenic expression and low
immunogenicity. Typically, when AAV therapies are delivered systemically, the vast majority of AAVs are
sequestered in the liver, with little expression in target tissues. This effect causes a narrow therapeutic
window, as systemic AAV must be dosed near toxic levels to attain therapeutic benefits. To overcome these
challenges, Zvelt has developed Rec2-leptin/dual cassette, an AAV based leptin gene therapy for the
treatment of lipodystrophy that preferentially targets fat cells/adipose tissue while restricting
transgene expression in the liver. In previous STTR Phase I, we have already demonstrated that a single
intraperitoneal (IP) injection of Rec2-Leptin/dual cassette in ob/ob mice (murine model of lipodystrophy) can
normalize the metabolic syndromes without adverse effects even at the lowest dose tested (1E9 vg/mouse)
and the transgene (leptin) expression was restricted to the targeting tissue - visceral fat and not in the liver.
In this STTR Phase II, we will determine minimum Effective Dose (MED), establish safety and delivery route
[IP vs subcutaneous (SC)] and efficacy of Rec2-Leptin/dual cassette in aP2-nSREBP1c transgenic mice
(second murine model of lipodystrophy). Additionally, anti-Rec2 neutralizing antibody assay will be
standardised for both mouse and the non-human primate (NHP). Subsequently, the safety of different delivery
routes and doses and durability of efficacy of Rec2-leptin/dual cassette will be evaluated in African green
monkeys. The preclinical results of Phase II will contribute towards the pre-IND meeting with the FDA. Based
on the feedback from the agency, we will conduct a GLP toxicology study in wild type mice, using the same
drug product that was used in our NHP studies. We will then produce GMP drug and file an IND to conduct
a Phase I/II trial in lipodystrophy patients.

Public health relevance
PROJECT NARRATIVE Lipodystrophy, a rare and usually underdiagnosed condition that affects adipose tissues and manifests in various metabolic disorders has no definitive cure, with existing ones having low efficacy, adverse side effects, discomfort of use (1-2 injections per day), poor compliance and high costs. Zvelt Therapeutics’ novel Rec2-leptin/dual cassette gene therapy offers a promising treatment for lipodystrophy with its improved efficacy, safety, durability of at least 5 years and cost-effectiveness. The therapeutic injection, priced at approximately $2M will significantly reduce the lipodystrophy treatment cost per patient/year by at least 70% and thus, will improve patient compliance and outcomes to ultimately improve the overall QoL for patients and their families.